DETECTION OF MAJOR GENE LOCI FOR SCHIZOPHRENIA

This collaborative genetic project is designed to pursue the hypothesis that one or more major gene defects may be responsible for the inheritance of schizophrenia. A collection of at least 300 families with definite schizophrenia in at least two sibling are being sought and is predicted to have enough power for the detection of a genetic linkage in schizophrenia. Once a linked chromosomal region(s) have been found, we will proceed to locate specific genes involved. This will further our understanding of the etiology of this illness and new treatments for its cure.